Engaging men through HIV self-test and differentiated care models to increase ART initiation and viral suppression in Malawi

Project Summary
Men continue to be missed by HIV testing and treatment services. Index partner testing is a critical strategy for
reaching men. Index HIV self-testing (HIVST), whereby ART clients take HIVST kits home to their sexual partners
for testing, is a new strategy that dramatically increases index testing among men, and is being taken to scale
across Malawi. However, only 25% of men identified as HIV-positive through Index HIVST initiate ART after 6-
months. Innovative strategies to increase ART initiation and retention among men are urgently needed. The
overarching goal of the proposed R01 is to test a home-based ART intervention (ART initiation + 3-months ART
care) plus motivational interviewing to increase ART initiation and 6-month viral suppression among men who
test HIV-positive through Index HIVST in Malawi. The specific aims are: (1) test the effectiveness of home-based
versus facility-based ART on ART initiation and 6-month viral suppression among male partners who test through
Index HIVST; (2) Identify predictors of ART initiation and 6-month viral suppression; and (3) Determine the cost
and cost-effectiveness of home-based ART versus facility-based among male partners using Index HIVST. The
trial will provide urgent information on innovative HIV service delivery strategies for hard-to-reach-populations,
such as men. Findings are expected to inform national policy and international recommendations around
combined differentiated models that reach across the HIV treatment cascade.

Public health relevance
Project Narrative Men in sub-Saharan Africa who test HIV-positive continue to have poor ART initiation and retention outcomes. The proposed project will test a home-based ART intervention for men who use HIV self-testing (HIVST) strategies compared to facility-based ART. Findings will provide essential information on how to best reach men across the testing and treatment continuum, a critical step to curbing the HIV epidemic.